Re-engineering Precision Therapeutics Through N-of-1 Trials

The objective of this proposal is to develop, test, and implement an innovative technology platform for conducting
N-of-1 trials that transforms precision therapeutics. Right now, clinicians are engaging in clinical encounters at
which they are trying to determine the best therapy for individual patients. These encounters are likely to be
unsuccessful. Clinicians rely on the best available evidence (e.g., results from phase III randomized clinical trials;
RCTs) for recommending therapies to a patient. Yet, conventional, between-patient RCTs only provide estimates
of the effect of therapies on the average patient in those trials. Individual patients, however, often respond
differently than the average patient in the phase III RCTs, and thus, heterogeneity of therapy response plagues
these clinical decisions every day.
The most scientifically rigorous-- and potentially transformative--method for determining optimal therapy for apatient is a single-patient (N-of-1) trial. N-of-1 trials are multiple crossover trials, usually randomized, and often
masked, conducted within a single patient, with data collected objectively, continuously, and in the real-world, for
a sufficient time period to determine whether the therapy, compared to a placebo or other active therapy, is
optimal for a particular patient. They also yield information on off-target actions, such as side-effects, so that a
more complex picture can emerge about the overall benefits and harms of a therapy for an individual patient.Clinicians and patients do not routinely engage in this type of scientific endeavor because they lack the tools.
In this proposal, we will create an electronic platform that will allow clinicians and/or patients to order and
conduct a single-patient trial. We will then collect RCT data to be able to estimate the benefit (if any) from using
this approach. To do so, we will conduct 3 experiments using our platform for 3 different health conditions, each of
which has high public health burden, high heterogeneity of therapy response, and high priority for a precision
therapeutics approach as determined by previously interviewed clinicians and patients. For each, we will
randomize 60 patients to receive an N-of-1 trial, or to receive usual care. We will then test a pragmatic design that
simulates how the platform will be implemented in clinical practice after its release date. The application will be
embedded in the clinical workflow, with clinicians having the capability of referring and tracking their patients in
N-of-1 trials directly through the electronic health record. In this experiment, we will randomize 200 patients to
receive the pragmatic N-of-1 trial, or to receive usual care. We will thus be able to compare our new precision
therapy approach to the way therapies are typically determined for a patient.
This N-of-1 trials platform will also facilitate a paradigm-shifting approach to discovery of therapeutic response
phenotypes, as we will build a public facing registry of N-of-1 protocols and tools and a repository of de-identified
data from N-of-1 trials. This international database of N-of-1 trial results can then be mined to identify phenotypes
categorized by treatment responsiveness.

Public health relevance
We need to re-imagine the clinical encounter at which therapies are selected, into one that is capable of identifying therapies with maximal benefit and minimal harm for individual patients. Such a precision therapeutics clinical encounter requires de novo creation and extensive testing of an automated electronic platform that would allow clinicians (or patients, or scientists) to collect objective, real-world outcome data on the usefulness of a therapy for an individual patient. In the spirit of groundbreaking, paradigm-shifting research, we propose to re-engineer clinical practice, to make N-of-1 trials accessible and feasible so that precision therapeutics can become widely available.